Genetic dissection of mitonuclear interactions in aging and neurodegenerative disease

ABSTRACT
Mitochondria are ancient cellular “powerhouses” critical to energy metabolism. They contain their own,
maternally transmitted genome (mtDNA) that encodes 13 components required for oxidative
phosphorylation, but the remaining >99% (~1100 proteins) of its proteome, including all proteins required
for mtDNA replication and maintenance, is encoded by the nuclear genome. mtDNA is a high copy number
genome, and when a cell contains a mixture of wild-type and mutant mtDNA molecules, a state of
“heteroplasmy” results. It has long been known that as we age, our mtDNA copy number declines and
mtDNA mutational heteroplasmy accumulates. A decline in mtDNA copy number has also been
documented in the blood and brains of patients with Alzheimer’s disease, while an accumulation of mtDNA
heteroplasmy has been documented in Parkinson’s disease and Lewy body dementia. At present we do
not know the origins of these mtDNA alterations and whether they contribute in a causal way to Alzheimer’s
disease and related dementias (ADRD), but certainly, mitochondrial interactions are key. Understanding
mitonuclear interactions has historically been challenging due to a lack of key technologies. During the
past four years our lab has contributed to two technological advances that will now transform our approach
to mitonuclear genetic interactions: (i) mtDNA editing using ddCBE base editors (as CRISPR doesn’t work
in mitochondria) and (ii) biobank-scale analysis of mtDNA copy number and heteroplasmy across hundreds
of thousands of humans. In this grant we propose to leverage these two new technologies to systematically
investigate how mitonuclear interactions contribute to aging and age-associated neurodegenerative
diseases such as Alzheimer’s disease. We anticipate generating an experimentally validated inventory of
nuclear genes and proteins that control mtDNA copy number. Importantly, we will also better understand
if and how mutations in the nuclear genome interact with mutations in the mtDNA to contribute to ADRD.

Public health relevance
PROJECT NARRATIVE Mitochondria are the “powerhouses” of the cell and are responsible for generating the bulk of our cellular energy. Instructions for making mitochondria is contained in two different types of DNA, one that we inherited from both parents, and one that we inherit from only our mothers. These two types of DNA must communicate with each other for mitochondria to properly function. As we age, communication between these two types of DNA appears to be breaking down, especially in the brains of patients with Alzheimer’s disease and related dementias. In this grant we will use cutting edge new methods in genetics to understand how these two different types of DNA communicate with each other in health, and how they break down in aging and in neurodegenerative disease.